Formation of a Novel SARS-CoV-2 Nucleocapsid Dimer: Impacts on Viral and Cellular Processes

While most SARS-CoV-2 research to date has focused on the biological consequences of mutations seen in the
Spike (S) protein, the nucleocapsid protein (N) is also under selective pressure and an array of mutations within
this protein have been documented in different Variants of Concern (VOCs). In this study, we identified three
SARS-CoV-2 variants (Beta, Iota, and Delta) that encode different cysteine mutations, all introduced into the
linker region of N. These mutations facilitate a highly stable N-N dimer mediated by the introduction of a cysteine
and the formation of a di-sulfide bond. Beta, Iota, and Delta variants isolated and grown at BSL-3 all contained
a novel cysteine residue in the linker region of N, which appear to be unique introductions amongst pandemic-
causing Betacoronaviruses. Nucleoproteins encoding these cysteine mutations and transiently expressed in
HEK-293T cells also form a dimer in the absence of other viral machinery. Removal of these cysteine mutations
in the linker abolishes dimer formation. Notably, our biochemical studies also revealed this dimer is highly stable
and can be visualized on standard non-reducing SDS-PAGE gels. Our proposal focuses on the G215C mutation,
which quickly rose to dominance within the Delta lineages and mutations back to wildtype within transmission
chains were quickly followed by a reversion to a cysteine at this position. Using reverse genetics, Drs Johnson
and Menachery will construct a SARS-CoV-2 Delta virus that reverts the nucleocapsid cysteine back to the
ancestral sequence to specifically evaluate N dimer impact on infection. This proposal aims to study the biological
impact of stable N dimer formation during infection by characterizing viral growth kinetics (in vitro and in vivo) as
well as the effect on viral fitness and transmission in the hamster model. Notably, a related virus (G215C in the
WA1 background) showed substantially increased growth both in vitro and in vivo, suggesting that stable N dimer
formation is important for viral replication. The stably dimerized form of N is highly enriched in virions (vs. the
cellular environment) and we hypothesize it is increasing the efficiency of encapsidation and thus the stability of
the viral RNA during transmission. As the cysteines we observe in the nucleocapsid linker lie near/on the N/NSP3
binding interface we will use proteomics to determine how the cellular and viral binding partners of the
nucleoprotein change with/without this disulfide bond. Overall, the observation that mutations introducing a
cysteine in the N linker have arisen multiple independent times and been maintained during human transmission,
as well as our preliminary viral growth kinetics suggest that stable N dimer formation may drive positive selection
and convey a growth advantage during SARS-CoV-2 infection and/or a selective benefit during animal-to-animal
transmission.

Public health relevance
Novel emerging variants of SARS-CoV-2 threaten our ability to control the COVID-19 pandemic. Over the last several years multiple different variants have appeared, each with different mutations in a range of viral proteins. While the mutations in the spike protein that is the main target of current vaccines have been well studied, much less is understood about mutations that have appeared repeatedly in other viral proteins. We propose to study a set of mutations in the nucleocapsid that occurred in multiple Variants of Concern which resulted in the formation of a stable protein dimer. We will study what role this dimer plays in viral growth and infectivity, and how viruses that make it differ from the original virus that first spread in 2020. This study is important because mutations that result in the formation of this dimer have arisen multiple independent times during the pandemic, and this improved understanding will help us understand the biological impact of these changes.